The role of BET proteins in pathological cardiac remodeling

ABSTRACT
In response to persistent neurohormonal/hemodynamic stress or injury, the heart undergoes a pathologic
remodeling process typically characterized by cardiomyocyte hypertrophy and fibrosis. Cardiac fibrosis,
defined as excess extracellular matrix deposition in the heart, is a major contributor to both systolic and
diastolic dysfunction for millions of heart failure patients. Upon injury, resident quiescent fibroblasts undergo a
cell state transition to become activated fibroblasts and myofibroblasts that hyper-secrete extracellular matrix
proteins and can be contractile. Fibrotic remodeling causes stiffening of the left ventricle, impaired relaxation,
reduced compliance, and altered electrical conductance. This drives disease progression and worsens
pathology. Despite the well-known contribution of cardiac fibrosis to adverse outcomes associated with heart
failure, effective therapies targeting fibrosis in the heart remain elusive. Inhibition of the BET (bromodomain
and extra-terminal domain) family of epigenetic reader proteins with chemical small molecules (e.g. JQ1) has
proven effective at blocking in vivo cardiac hypertrophy, inflammation, and fibrosis and preserving cardiac
function in rodent models of heart failure. Though these inhibitors block all BET proteins in the heart (BRD2,
BRD3, BRD4), genetic targeting of individual BET proteins in cell culture experiments support the notion that
BRD4 is the main BET protein responsible for activation of pathologic gene expression programs in
cardiomyocytes and cardiac fibroblasts. However, recent work has given insight on the cell-type specific role of
BRD4 in cardiomyocytes, uncovering an essential role for BRD4 in maintaining mitochondrial homeostasis.
Conditional deletion of BRD4 in adult cardiomyocytes resulted in progressive cardiac dysfunction, impaired
mitochondrial function, and eventual death in mice. Taken together with previous studies, this suggests that the
beneficial effects of small molecule BET inhibitors in mouse models of heart failure are unlikely to be mediated
exclusively by inhibition of BRD4 in cardiomyocytes. We hypothesize that genetic in vivo disruption of BRD4 in
activated fibroblasts will safely block fibrosis and that multiple BET proteins (i.e. also BRD2 and BRD3)
mediate the beneficial effects of small-molecule pan-BET inhibition. In Aim 1, we will determine the in vivo role
of BRD4 in activated fibroblasts, and in Aim 2 we will elucidate the previously unexplored role of individual
BET proteins in cardiac cell gene expression regulation through ChIP-Seq. This work will be carried out in the
laboratory of Dr. Matthew Stratton, an expert in epigenetic regulation of pathologic cardiac remodeling, and
under the co-supervision of Dr. Loren Wold, a world-leader in cardiac physiology. Our long-term goal is to
develop safe and effective therapeutics to improve clinical outcomes for patients with cardiac fibrosis and HF.

Public health relevance
NARRATIVE Fibrosis in the heart is bad and contributes to poor survival for patients with heart failure, which afflicts millions of Americans, yet no effective treatments for fibrosis in the heart are available. Using special (genetically modified) mice, the proposed study will determine if targeting a specific protein, BRD4, in fibroblasts might work as a treatment for fibrosis in the heart and will determine if other proteins in the same family are important for turning on and off specific genes in the heart. Together, this work will help us understand how cells in the heart become disease activated and help us progress toward finding better treatments for heart failure.